Training in the Pharmacological Sciences

The mission of UVA’s predoctoral Pharmacological Sciences Training Program (PSTP) is to foster scientific
inquiry using pharmacologic strategies to address important biomedical questions. With this application, we
request funds to support 7 predoctoral trainees, who will be appointed to the training grant during their second
and third years of study. The PSTP curriculum includes rigorous didactic instruction and three research
rotations during the first year with selection of a thesis advisor in February of that year. During the second
year, students develop an independent research project and take a written and oral advancement to candidacy
examination. The following three years consist largely of a research project focusing on collaboration and
publication culminating in a written dissertation and seminar. Integral to the PSTP are activities that enable
trainees to: a) understand responsible conduct of research (RCR) and laboratory safety, b) develop skills in
rigor & reproducibility, c) receive and give feedback during evaluation, d) develop career interests, including
use of Individual Development Plans, e) improve written and oral communication skills, and f) learn critical
analysis via journal clubs and seminars. Research in the PSTP is inter-disciplinary and includes intermediary
metabolism, neuroscience, infectious disease, immunology, membrane biophysics, drug discovery and design,
and proteomics. The PSTP is based in the Department of Pharmacology and nearly all trainees are
Pharmacology PhD students with an occasional Neuroscience program PhD student. The PSTP preceptors
are 25 faculty drawn from 8 different academic departments across UVA’s research enterprise. These faculty
are evaluated by the PSTP Steering Committee for research excellence, mentoring skills, and commitment to
diversity. Faculty are required to compete mentor training before accepting a PSTP trainee. Oversight of the
PSTP program is achieved by the Steering Committee aided by an expert Internal Advisory Committee. The
PSTP builds on 45+ years of educational excellence in the Pharmacological Sciences that has no equivalent
elsewhere at UVA. Historically, the PSTP mentors have included 2 Nobel laureates. Approximately 8 students
are enrolled annually from a pool of ~200 applicants after a rigorous, holistic application process culminating
with in-person interviews. Matriculants from under-represented minority (URM) groups now represent ~20% of
the total, with an overall F:M ratio of ~2:1. The URM candidates, those from disadvantaged backgrounds and
students with disabilities are actively sought in outreach programs such as a highly successful undergraduate
Summer Research Training Program (SRIP). UVA PSTP graduates are highly sought-after in academia,
industry, and public service due to their excellence as research scientists.

Public health relevance
Project Narrative The UVA Pharmacological Sciences Training Program (PSTP) teaches talented scientists to apply innovative approaches to pressing biomedical problems using Pharmacologic methods. Our diverse graduates are poised to become the next generation of leaders in academia, government and the pharmaceutical industry.